The structure and function of metabolic filaments

PROJECT SUMMARY
Intermediate metabolism must be finely tuned, carefully balanced, and robustly adaptable to changes in
environmental conditions. While the individual enzymes that drive most metabolic processes are well
understood, only recently has the field come to appreciate the widespread role of metabolic enzyme self-
assembly in metabolic organization and control. In particular, we now know that dozens of metabolic enzymes
assemble into filamentous structures in vivo and in vitro, and that these filaments act as allosteric effectors to
tune enzyme activity. This proposal focuses on self-assembled filaments of metabolic enzymes in glycolysis and
nucleotide biosynthesis, processes that extract energy from sugar and generate fundamentally important
macromolecular building blocks, respectively. We will use cryo-electron microscopy to determine the structural
basis for assembly and regulation, coupled with biochemical, biophysical, and cell biological approaches in an
integrative approach to understanding metabolic filament function. This work will provide insight into the specific
roles polymerization plays in modulating enzyme function, and illuminate general principles of metabolic control
by enzyme filaments. This request for an administrative supplement is to fund acquisition of a mass photometer,
a device for directly measuring the sizes of individual molecules in a population, which will allow us to monitor
assembly state of the enzymes in our studies. This is particularly critical for quantitatively assessing the functional
consequences of enzyme assembly.

Public health relevance
NARRATIVE The fundamental processes of metabolism — breaking down nutrients to generate energy and using that energy to create the molecular building blocks of life — take place in a highly organized environment inside cells. In response to changes in environmental conditions many enzymes that control cellular metabolism dynamically reorganize into large filamentous structures, which regulate the speed of metabolic reactions. We propose to study the role of these important metabolic filaments in producing energy from sugar, and in creating the molecular building blocks of DNA and RNA, to understand how metabolic processes are regulated, how their misregulation causes disease, and how they can be manipulated in new medical therapies.